Timing and regulation of meiotic commitment

Project Summary/Abstract:
Meiosis is the cell division process in which a diploid cell undergoes one round of DNA replication
followed by two rounds of chromosome segregation to ultimately produce haploid gametes. Errors in meiotic
chromosome segregation can result in miscarriage and trisomy conditions, such as Down syndrome.
Therefore, studying meiotic chromosome segregation is important for understanding how errors in this process
occur. The objective of this proposal is to determine the mechanisms that regulate proper chromosome
segregation, focusing on unique events in meiosis I and meiosis II. These studies leverage the model organism
S. cerevisiae, due to the ease of developing tools to address mechanistic questions. These innovative tools will
allow the investigation of how cells establish microtubule-kinetochore attachments, how cells correct improper
attachments, and how cells monitor the attachments through spindle checkpoint activity, which delays the cell
cycle in the presence of unattached kinetochores. The rationale for the proposed research is that the questions
focus on processes that are unique to meiosis but are likely to be highly conserved, allowing the findings in
budding yeast to uncover general mechanisms of meiotic regulation. Strong preliminary data guide the
following three specific aims: 1) determine how the number of crossovers and crossover position along the
chromosome affects the establishment of correct kinetochore-microtubule attachments in meiosis I; 2)
investigate how cells prevent persistent spindle checkpoint activity during meiosis; and, 3) determine how the
phophoregulation of proteins at the meiotic kinetochore ensure proper kinetochore-microtubule attachments in
meiosis II. In the first aim, strains have been developed to target crossovers at particular locations on a
chromosome arm. Using time-lapse imaging, the strains will be monitored for the timing of establishing
bioriented kinetochore microtubule attachments, and for the number of rounds of error correction of improper
attachments. The second aim tests the novel hypothesis that cells have a developmentally programmed
mechanism to overcome persistent spindle checkpoint activity in meiosis to ensure the production of gametes.
The third aim analyzes how protein phosphatases counteract kinase activity to specifically ensure kinetochore
assembly and the establishment of kinetochore-microtubule attachments specifically in meiosis II. The
innovative approach of combining the latest imaging technologies to monitor kinetochore-microtubule
attachments in engineered strains allows the testing of novel hypotheses about cell-cycle regulation. The
proposed research is significant because the results are expected to reveal general principles of meiotic
regulation important for proper chromosome segregation. Ultimately, the results will further our understanding
of how errors in meiosis facilitate developmental abnormalities.

Public health relevance
Project Narrative The goal of this proposal is to provide insight into the cell division process of meiosis, which is essential for the formation of gametes, such as eggs or sperm. Errors in meiosis can cause a gain or loss of genetic material in the gametes, which can lead to miscarriage, infertility, and trisomy conditions. The experiments in this proposal address the fundamental question of how errors in meiosis occur so that we can learn how to prevent them.